CURIOUS: Cardiovascular Undergraduate Research Initiative fOr Underrerepresented Students

ABSTRACT
The LSU Health Sciences Center in Shreveport (LSUHSC-S) has seen a steady increase in grant funding in
the past few years, in particular in the area of cardiovascular diseases. Areas of research focus include
atherosclerosis, myocardial infarction, cardiomyopathy, peripheral artery disease, microvascular dysfunction in
response to cardiovascular disease risk factors, stroke and the vascular/heart-brain axis. Principle
Investigators leading this research are members of our Center for Cardiovascular Diseases and Sciences
(CCDS). Their efforts now consistute more than 50% of total NIH funding at LSUHSC-S. There is considerable
cross-collaboration and sharing of expertise between CCDS members, positioning us to focus on training
young researchers in cardiovascular diseases. We have identified undergraduate students as the population
least served in terms of research experience on our campus. Therefore we propose the development of the
Cardiovascular Undergraduate Research Initiative fOr Underrepresented Students (CURIOUS) Program. This
will be an intensive 8-week summer research program targeted at underrepresented students from all over the
USA, but with particular emphasis on the 6 four-year universities in the northwest Louisiana region, and
surrounding states where there are large underserved populations and high rates of cardiovascular disease.
Students will have 8 weeks of research in a lab with a cardiovascular-related focus, complemented by didactic
lectures in the responsible conduct of research, interaction with seminar speakers invited specifically for the
students in this program, and lunches to informally learn about student life, diversity and financial
preparedness for graduate school. In addition there will be 2 types of weekly experiences: 1) cardiovascular
basics, and state-of-the-art techniques that will give students an introduction to basic cardiovascular anatomy
and pathology before teaching them advanced techniques we use to interrogate cardiovscular disease, such
as echo and endoPAT; and 2) career development in which there will be introduction to the medical and
graduate school, as well as cardiopulmonary sciences, workshops on how to present yourself, write a CV,
interview, and design a poster. Finally the students will present a poster in a designated poster session our
LSUHSC-S. We will emphasize retention of students for 2 summers, and provide more advanced versions of
the weekly experiences in year 2, culminating in an oral presentation. For the top-performing students, we will
offer the opportunity to attend and present at a national conference. Therefore the CURIOUS program will
enhance the research training of underrepresented undergraduates in the area of cardiovascular disease, and
expose them to multiple career paths in which they can continue to pursue research. Overall, this effort is
designed to improve the workforce available to move research on cardiovascular disease forward at a national
level.
!

Public health relevance
NARRATIVE In a collaborative effort among the faculty members of our Center for Cardiovascular Diseases and Sciences, we will harness the recent growth in funding for cardiovascular-related research at LSUHSC-S, to develop the Cardiovascular Undergraduate Research Initiative fOr Underrepresented Students (CURIOUS) Program. This is an 8-week intensive summer research program with a cardiovascular disease-related focus, targeted at underrepresented students nationwide. Our goal is to enhance the exposure of underrepresented undergraduates to research, teach them state-of-the-art techniques, and provide them with career development that prepares them to be strongly competitive for entry into, and successful completion of, advanced degrees, ultimately leading to careers that encompass cardiovascular research.